Georgetown-Howard Universities Center for Clinical and Translational Science (GHUCCTS)

The Georgetown-Howard Universities Center for Clinical and Translational Science (GHUCCTS) is a primary
partnership of Georgetown University (GU) and Howard University (HU), with 3 affiliated institutions: MedStar
Health Research Institute (MHRI), Oak Ridge National Laboratory (ORNL), and the Washington DC Veterans
Affairs Medical Center (DCVAMC). This application is for our second competitive renewal. The specific aims of
GHUCCTS are presently: 1) To continue to improve the infrastructure that supports high quality, interdisciplinary
clinical and translational research, both via inter-institutional collaborations among GHUCCTS institutions as well
as multicenter clinical trials across the national CTSA consortium, with increasing efficiency; 2) To further establish
GHUCCTS as a model of inter-institutional collaboration that leverages the strengths and attributes of its diverse
participating institutions in order to maintain GHUCCTS as a regional CTSA hub with unique and synergistic
strengths; 3) To leverage our location, expertise and the co-leadership of a minority-serving institution to design,
implement and disseminate clinical and translational research that will have a high impact on populations with
health disparities, particularly underserved groups in our communities who have been historically under-
represented in clinical research studies, including people from diverse racial, ethnic, and cultural backgrounds,
people with disabilities, older adults and Veterans; 4) To continue to provide new vibrant and innovative
educational programs for multiple levels of trainees, faculty and staff that promote principles of team science, and
to provide the high quality career development training and support for the clinical and translational investigators of
the future; and 5) To continue to apply and develop innovative analytical and computational methods to speed and
enhance translation. In achieving these specific aims and their corresponding strategic goals we will draw from
and contribute to the collective efforts and mission of the National Center for Advancing Translational Science
(NCATS), and the national CTSA consortium.
In the first 8 years as a funded CTSA program, GHUCCTS evolved into a fully functional multi-institutional center
that has transformed CTR across each of the GHUCCTS member institutions with growing inter-institutional and
inter-disciplinary collaboration and mentorship. Enrollment of under-represented groups is high in our research
studies, and have increased to levels that more than double the national CTSA hub mean in our training
programs. We have designed a new core in collaboration with ORNL that leverages their novel technologies to
address environmental determinants of health risk in the District of Columbia. We will continue designing and
refining innovative GHUCCTS programs to train the clinical and translational scientists and leaders of the future,
and to disseminate these educational programs across the full spectrum of students, trainees and healthcare
professionals at our GHUCCTS institutions and the national CTSA network.

Public health relevance
PROJECT NARRATIVE The Georgetown-Howard Universities Center for Clinical and Translational Science (GHUCCTS) is a partnership of Georgetown University, Howard University, MedStar Health Research Institute, the Washington DC Veterans Administration Medical Center, and Oak Ridge National Laboratory. Through this innovative collaboration, GHUCCTS has been a catalyst for developing collaborations between institutions and disciplines, and transforming clinical translational research and training in the greater Washington DC region. We will continue to accelerate the translation of scientific discoveries into improved patient care and public health by supporting projects that address health concerns of our communities in the Washington, DC region and the nation.